Learning features of optimal CAR T cells for LBCL from patient data

PROJECT SUMMARY/ABSTRACT
Chimeric antigen receptor (CAR) T cells have emerged as breakthrough treatments for patients with hematologic
malignancies, earning 12 approvals from the U.S. Food and Drug Administration (FDA) since 2017. Experimental
CAR T cell therapies have also demonstrated complete remissions in solid tumors, and the FDA is projecting to
grant 10-15 approvals per year by 2025, highlighting the potential of these ‘living therapies’. Despite this, current
CAR T cell designs have not yet mediated sustained efficacy in solid tumors, and only 30-50% of B cell leukemia
and lymphoma patients experience long-term disease control. To develop safe and potent next-generation CAR
T cell therapies, it is critical to understand why existing CAR T cells succeed or fail in patients. As a scientist
trained in both experimental and computational immuno-oncology, I have chosen to focus my career on using a
systems biology approach to uncover the molecular mechanisms governing efficacy of engineered T cell
immunotherapies. This proposal outlines a structured 2-year training plan and a comprehensive 5-year career
development program to complete my training and launch an independent research career. My specific research
goals are: (1) to define the most therapeutically relevant CAR T cell subsets in patients with large B cell
lymphoma (LBCL), and (2) to overcome an immune suppression mechanism of resistance to CAR T cell therapy
for LBCL. First, I will follow individual CAR T cell clones through time in patients treated for LBCL using matched
single-cell sequencing of transcriptome, a panel of surface proteins, and endogenous T cell receptors (Aim 1).
This approach, termed reverse fate mapping, will pinpoint T cell clones in the pre-manufacture apheresis and
infusion products with sought-after properties, including abilities to expand, persist, and home to the tumor. In
Aim 2, I will apply reverse fate mapping and methylation analyses to identify the origin of circulating CAR T
regulatory (Treg) cells that I recently linked to limited CAR T cell efficacy in LBCL. In Aim 3, I will mechanistically
dissect the interplay between Treg and non-Treg CAR T cells to design a potent ‘Treg-free’ CAR T cell therapy for
clinical evaluation. My work will generate a comprehensive CAR T cell atlas and insights, leading to promising
avenues for engineering the next-generation CAR T cell therapies. The results of my proposed research will
positively impact public health, as they will gather sufficient preliminary data for testing a ‘Treg-free’ CD19-CAR T
cell therapy for LBCL in a clinical trial and will deliver fundamental insights into CAR Treg biology that may
generalize to other diseases, including solid tumors, where engineered T cell therapies have not manifested
similarly potent effects as in LBCL. To build upon my skills, I have assembled a mentorship team, including my
primary mentor, Dr. Crystal Mackall, a pioneer in CAR T cell immunotherapies; co-mentor, Dr. Sylvia Plevritis, a
leader in cancer systems biology; and an advisory committee with extensive expertise relevant to all aspects of
this proposal. The completion of this K99/R00 program will prepare me to compete for R01 funding and to launch
an independent research career focused on improving immunotherapies for patient with cancer.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor (CAR) T cell therapies have revolutionized treatment options for patients with hematologic malignancies and hold promise for other types of cancer. However, limited CAR T cell expansion, persistence, and immune suppression from T regulatory (Treg) cells limit efficacy of CAR T cell therapies for large B cell lymphoma (LBCL). This proposal will: (1) employ fate mapping to identify drivers of desirable T cell states in pre-manufacture apheresis and infusion products with optimal expansion and persistence properties, and (2) mechanistically dissect and evaluate methods to overcome Treg suppression, providing a platform to improve CAR T cell therapy treatment options for patients with cancer.